AMC008: IL2 FOLLOWING IFOSFAMIDE/ETOPOSIDE FOR HIV NONHODGKIN'S LYMPHOMA

Chemotherapy is the most effective treatment for AIDS-related NHL, although complete remissions occur in only 50%. No treatment has been defined for patients who relapse or fail to respond to initial treatment. Continuous infusion chemotherapy using ifosfamide and etopside has shown anti-tumor activity in patients with relapsed or refractory AIDS-NHL, but of limited response duration. We wish to see if additional biologic therapy with either IL-2 or IL-12 given after remission to chemotherapy will be associated with prolonged responses compared to observation alone.